SEARCH FOR IMPAIRMENT IN PTH-MEDIATED RENAL CALICUM TRANSPORT

Overall objective is to develop a more coherent understanding of the etiology and pathophysiology of the age-related bone loss that leads to osteoporosis.